A Pilot Clinical Trial of Paricalcitol for Chronic Pancreatitis

ABSTRACT
The primary objective of the proposed trial is to examine the feasibility of testing the effect of a
potent vitamin D analogue, paricalcitol, on health-related quality of life (HRQoL), and imaging and liquid
biomarkers in patients with chronic pancreatitis (CP). If determined feasible, subsequent trials will be
developed that focus on the efficacy of paricalcitol in improving outcomes in CP. Tragically, pain has
the most important influence on diminished HRQoL and increased resource utilization in pancreatitis
patients. Development of clinical trials in CP patients to improve treatment options, attenuate symptoms,
and prevent exocrine function failure, diabetes and pancreatic cancer is widely considered an area of
enormous unmet need. There is a substantial body of preclinical evidence that potent vitamin D
analogues have significant and beneficial effects on both pancreatitis and pancreatic cancer by blocking
Transforming Growth Factor Beta (TGFβ) signaling and reducing pain.
We hypothesize that paricalcitol treatment will improve symptoms, as measured by patient reported
HRQoL, and normalize imaging and liquid biomarkers of the pancreatic fibro-inflammatory process in
this high-risk patient population. Because surrogate biomarkers of response to therapeutics have not
been developed for CP, early trials such as this one are needed to assist with biomarker discovery for
future validation. We propose a pilot randomized double-blind, placebo-controlled trial to evaluate the
feasibility and safety of a 12-month paricalcitol intervention versus placebo administration. We will
collect measures of HRQoL, and changes in measures (imaging and liquid) of the fibro-inflammatory
response. We will randomize 24 CP patients 1:1 to paricalcitol vs placebo with a 21-month recruitment
period and a one-year follow-up period. Importantly, our efficient study design will enroll patients who
are participants in our ongoing prospective longitudinal cohort study, PROCEED (PROspective
Evaluation of Chronic Pancreatitis for EpidEmiologic and Translational StuDies), which is conducted
under the auspices of the US Consortium on Chronic Pancreatitis, Diabetes and Pancreatic Cancer
(CPDPC). Nesting in the PROCEED study provides a well-defined clinical cohort of patients who are
under frequent medical surveillance allowing us to harmonize patient recruitment, collection of biological
specimens, and follow-up with routine clinical and research appointments and tests, ensuring high rates
of recruitment and retention. Feasibility will be met if the proportion of patients who enroll and complete
the 12 months of paricalcitol therapy is ≥75% of planned. Importantly, this trial will provide a platform
for study design and measurements needed for implementation of potential treatment agents for CP.

Public health relevance
NARRATIVE Chronic pancreatitis is a progressive fibro-inflammatory disorder of the exocrine pancreas that can lead to diabetes and pancreatic cancer. There are no available treatments for this fibro-inflammatory disease and patients suffer with unremitting abdominal pain as the disease progress. This pilot study will test the feasibility of conducting a clinical trial of a potent vitamin D analogue, paricalcitol, to enhance the quality of life and delay disease progression in chronic pancreatitis patients.